Effects of health policy on the health of people with systemic autoimmune and rheumatic diseases

ABSTRACT
Systemic autoimmune and rheumatic diseases (SARDs) most often occur in females (80% of people
with autoimmunity are female). Past research has shown that women with SARDs have a significantly
increased risk of adverse pregnancy outcomes compared to the population average. However, little
research has investigated how health policies affect the delivery of healthcare to people with SARDs,
and how this might affect their health during reproductive years and during the pregnancy and
postpartum period. Pregnant individuals with SARDs will be directly affected by health policies that
affect their access to high quality care. Health policies are also likely to affect non-pregnant females,
particularly around healthcare quality, access to effective treatments, and health outcomes. The medical
decision-making of rheumatologists—specialists in the healthcare of people with SARDs -- may also be
affected by health policies. Using multi-method approaches, this study will provide an assessment of
how health policies are affecting the health outcomes and healthcare of reproductive-age females with
SARDs. Stratifying by state policy context, we will qualitatively interview patients with SARDs who are
currently pregnant to understand their experiences with fertility and access to pregnancy care. We will
interview rheumatologists to assess how policy influences medical decision-making, prescribing
practices, and referrals for pregnancy and perinatal care. Using national claims data, we will evaluate
pregnancy outcomes among women with SARDs (e.g., severe maternal morbidity), and healthcarerelated outcomes among non-pregnant women with SARDs (e.g., prescription medication use).
Findings from the study will inform a policy and public health response that enhances patient-centered
healthcare for women with SARDs

Public health relevance
NARRATIVE Recent federal and state changes in health policies could impact the health and well-being of reproductive-age females with systemic autoimmune and rheumatic diseases (SARDs). The RESPOND study will elicit data that highlight the impact of health policies on this group. Our findings will create a foundation for the development of novel, evidence-based interventions that will preserve patientcentered rheumatology care.